SAFETY, EFFICACY AND TOLERABILITY OF LDL SPECIFIC APHERESIS

The purpose of this study is to determine the rate of rebound of LDL cholesterol, as well as other lipoproteins, in two homozygote FH patients who are having weekly LDL-specific affinity apheresis.